Flexible Hybrid Cloud Infrastructure for Seamless Management of HuBMAP Resources

Project Summary not required for PA‐20‐272 Administrative Supplements to Existing NIH Grants and Cooperative Agreements

Public health relevance
Project Narrative not required for PA‐20‐272 Administrative Supplements to Existing NIH Grants and Cooperative Agreements